Spatiotemporal Control of T cell Synapse Stabilization and Signaling

Project Summary/Abstract
T cells utilize surface-bound T cell receptors (TCR) at the immunological synapse with antigen-presenting cells
(APC). Detection of their peptide-MHC ligands results in rapid intracellular signaling, necessary for acquisition
of effector functions and for profound adaptive immunity. While we now understand some of the fundamental
proteins in this processing, understanding how each works together in the context of a rapidly moving T cell
has proven difficult.
TCR recognition happens as surface deformations provide initial contact. However, despite various fixed and
lower-resolution approaches to understanding this process, it has not been previously possible to study this
complete surface in real-time in the full 3-dimensions in which it takes place. Here, we will use novel and
advanced imaging approaches to define how cytoskeletally-driven membrane movements provide a backbone
for efficient ligand detection and we will describe how a range of widely variant environmental cues as well as
novel pathways alter this process and affect immune surveillance.
This project will define how T cells effectively `find' their ligands amidst a sea of competing MHC. This
efficiency of search and detection has clear implications for the ability of T cells to discovery rare epitopes and
initiate a response, for example during the early phases of a viral infection.

Public health relevance
Narrative T cells must scan their environment, remaining optimizing sensitivity and speed. This study will understand how immune cells are able to be both sensitive and efficient in surveying their environment. It will also help explain how ligands are sensed, through the stabilization of microvillar-projections.